The role of mitochondrial metabolism in weight loss

PROJECT SUMMARY
Obesity is a major risk factor for cardiovascular (CV) disease. Various CV risk factors like insulin resistance,
dyslipidemia, and inflammation are associated with mitochondrial dysfunction. Weight loss is the main
recommendation to reduce cardiometabolic risk for people with obesity, but the protection is proportional to the
magnitude of weight lost, and fades over time during weight maintenance with the reversal or worsened risk in
those who regain weight. This proposal aims to investigate mitochondrial adaptations with weight loss that
might lessen its capacity to protect against CV disease. We will do this by studying adaptation in the plateau
phase, a time period when further weight loss becomes minimal despite efforts to continue losing weight, and
weight regain often follows. The plateau phase is currently understudied and links the occurrence of a weight
loss plateau with diminished protection against cardiometabolic risk.
In AIM 1, I will determine functional differences in mitochondria at the weight loss plateau in immune cells
isolated from people with obesity undergoing weight loss. In AIM 2, I will develop paradigms of the plateau-
state in mice with diet-induced obesity to test whether reduced mitochondrial respiratory capacity in liver
muscle and immune cells is an underlying mechanism for adaptation in energy expenditure (metabolic
adaptation) at the plateau that promote weight regain. For AIM 3, I will determine in a mouse model of
accelerated atherosclerosis whether mice the plateau state develop more severe diet-induced CMR,
atherosclerosis, and immune cell redox stress.
This proposal will be carried out in an institution with strong research programs in metabolism, obesity, and
cardiovascular disease. I will receive state-of-the-art training in techniques and analytical tools necessary for
completion of all aims, including clinical samples from NIH-funded obesity studies, indirect calorimetry in
rodents, and assessment of atherogenic risk in mice. This proposal will generate data laying the foundation for
my independent research career focused on mitochondrial mechanisms that influence cardiometabolic risk in
obesity.

Public health relevance
Project Narrative In this proposal, we test the hypothesis that in the context of obesity, weight loss results in a plateau phase that is marked by a decrease in mitochondrial metabolism in multiple cell types (immune cells, hepatocytes, and myocytes) that give rise to reduced energy expenditure and increased susceptibility to cardiometabolic risk. These changes could contribute to the almost universal tendency for weight to be regained after weight loss by lifestyle changes, thus limiting the ability of weight loss to reduce cardiovascular disease risk over the long- term. Our results will provide new insights that could lead to future therapeutic approaches to promote the extent and maintenance of weight loss and reduce the cardiovascular risk associated with obesity.